Chromatin Remodeling and Lymphocyte Regulation

Previously, we found that chromatin remodeling was required for Th2 cytokine gene expression. As the remodeling enzyme bound to the affected loci, the role of the remodeling enzyme appears to be direct.[unreadable] [unreadable] Progress:[unreadable] [unreadable] We identified a transcription factor that associates with a remodeling enzyme in a cytokine-dependent manner.[unreadable] [unreadable] We identified two transcription factors that recruit a remodeling enzyme to the Th2 locus.[unreadable] [unreadable] We identified a transcription factor that facilitates binding of another transcription factor to the Th2 locus.[unreadable] [unreadable] We identified the version of a remodeling complex that regulates Th2 gene expression and chromatin structure.[unreadable] [unreadable] We identified another remodeling enzyme regulating activation-inducible genes in a T cell line.[unreadable] [unreadable] Future: [unreadable] Remodeling and other cytokine loci.[unreadable] Remodeling and other T cell fates.